OPEN LABEL TRIAL OF THALIDOMIDE IN TREATMENT OF REFRACTORY CROHNS DISEASE

The present trial is to assess the efficacy and tolerability of thalidomide in healing ulcers causing symptomatic Crohn's disease. Efficacy will be measured by the Crohn's Disease Activity Index, and a physician driven assessment of treatment goals. Safety will be assessed as a secondary objective by careful scruitiny for any adverse reactions, frequent pregnancy testing in women with childbearing potential and EMG monitoring in patients on long term treatment.